Impacts of hurricanes and social buffering on biological aging in a free-ranging animal model

Impacts of hurricanes and social buffering on biological aging in a free-ranging animal
model
Natural disasters are deeply damaging to human health and welfare. Such disasters have the
potential to accelerate the aging process, which is the primary risk factor for most diseases.
Identifying age-accelerating consequences of natural disasters and mitigating their impacts is
therefore critical. However, natural disasters do not affect all individuals equally - there is
abundant variation in individual health outcomes. Evidence suggests that social support is a
critical buffer against the consequences of adversity, including natural disasters. But precisely
how social support gets under the skin to mitigate disaster-linked declines in health and lifespan
remains elusive. Gaps in understanding are partly the result of ethical and logistical challenges to
the study of humans in disaster zones, including the availability of baseline data, and our ability
to quantify aging across more than a few domains (e.g., molecular markers in blood, physical
frailty). Humans are also very long-lived, impeding longitudinal study of accelerated aging within
individuals, and they tend to emigrate away from environmental catastrophes, biasing subject
pools toward certain members of affected populations. These difficulties can be overcome by
studying shorter-lived nonhuman primates, which share much of their biology and behavior with
humans, exposed to natural disasters.
The objective of this proposal is to leverage pilot data generated by a 1-year R56 (R56-
AG071023) in our long-term study of aging in the rhesus macaque population of Cayo Santiago
island, Puerto Rico, which was heavily impacted by Hurricanes Maria in 2017 and Fiona in 2022.
Our objective is to use this natural experimental model to quantify how natural disasters affect
biological age in multiple aging domains (molecular, physiological, physical), and to test if social
support buffers these effects.
We will quantify the effects of natural disasters on biological age and the pace of aging (Aim 1) in
three ways: (a) Using data, particularly post-mortem tissues, across individuals, we will test if
animals that experienced a hurricane exhibit older biological ages for their chronological age than
those who did not; (b) Using longitudinal data in the same living individuals we will test if their
pace at which they are aging is accelerated by a hurricane; (c) Comparing across Hurricanes
Maria and Fiona, we will quantify the cumulative age effects of natural disasters, predicting
individuals that lived through two disasters will appear biologically older for their chronological
age, and have a faster pace of aging, than individuals that only lived through one.
We will then quantify the extent to which social support buffers against the effects of natural
disasters on biological age (Aim 2), using data across aging domains. We predict that individuals
with greater social support will exhibit lower biological ages, and a slower pace of aging, in
response to a hurricane, and will be buffered from age effects accumulating over multiple
disasters.
Our study will provide unprecedented insights into fundamental questions about how natural
disasters affect the aging process, and how accelerated aging can be buffered by social
resources, in the most human-relevant animal model of health, disease, and aging – the rhesus
macaque.

Public health relevance
Impacts of hurricanes and social buffering on biological aging in a free-ranging animal model Age is the strongest predictor of risk for a multitude of diseases, yet the extent to which natural disasters impact aging remains unclear. This project investigates how and in what ways major natural disasters, in the form of hurricane impacts, have modified the pace of aging in a nonhuman primate model, the rhesus macaque. Our results will reveal how and to what extent natural disasters impact the onset of age-related declines, which will inform the targeted development of behavioral and physiological interventions that could reduce the burden of aging-related disease in our aging population.